Sex & Gender Informed Profiles of Eating Behaviors in Autism Across Childhood & Young Adulthood

PROJECT SUMMARY
Challenging or restrictive eating behaviors are well-documented in autistic individuals. Restrictive eating
behaviors, such as food selectivity, refusal and neophobia occur at a greatly increased rate in autism. Eating
disorders, such as anorexia nervosa, avoidant restrictive food intake disorder, and binge eating disorder, are
also diagnosed at highly elevated rates in autism. However, the associations between eating behavior profiles
and later clinical outcomes, such as eating order diagnoses, are poorly understood, with a lack of longitudinal
data to meaningfully capture these trajectories. This is an urgent research need given the clinical significance of
restrictive eating at a nutritional, behavioral, and social level.
Given the historic assigned sex at birth difference in autism diagnoses, most studies fail to fully consider the
role of sex on eating behaviors. However, in neurotypical populations, there are variations in challenging eating
behaviors and rates of eating disorders by sex. In more recent studies, these trends have been mirrored in
autistic samples. However, no study has considered the intersection of sex and gender on eating behaviors in
autism, despite the importance of gender in the development and maintenance of problematic eating behaviors
and eating disorders.
The overarching goal of this NIMH R03 is to leverage data across four existing cohorts of autistic and non-
autistic individuals, enriched for females and spanning a wide age range (4 to 39 years), to identify profiles of
eating behaviors in autism and determine how these vary by age, sex, and gender. Importantly, these studies all
employed harmonized measures of eating behaviors to achieve a total sample size of approximately 1,200
individuals. This R03 has two aims: (1) Using latent profile analysis (LPA), characterize profiles of eating
behaviors in a large sample of autistic and non-autistic individuals; and (2) Determine how profiles of eating
behaviors vary by diagnosis, age, sex and gender.
This R03 directly addresses NIMH Goal 2 to examine mental illness trajectories across the lifespan studying
eating behaviors across a wide age range, spanning early childhood through to adulthood, and pan-NIH goals,
including studying sex as a biological variable, the inclusion of gender within our analysis, and leveraging data
that focuses on an underrepresented population (autistic females). This data driven approach will enable us to
identify age-related trends in challenging eating behaviors in autism. Such data will allow us to generate
hypotheses that can be tested prospectively within our ongoing NIH-funded longitudinal samples, spanning early
childhood through to young adulthood, to understand the mechanisms by which challenging eating behaviors
escalate to an eating disorder.

Public health relevance
PROJECT NARRATIVE This study combines two priority areas for autism research: co-occurring conditions and the role of sex and gender. We will characterize how eating behavior profiles vary by diagnosis (autistic vs. non-autistic), sex, chronological age, and gender. Findings will expand the body of knowledge related to eating behaviors in autism, by identifying profiles that may predict risk for later eating disorders.